Hyperglycemia and increased severity to Staphylococcus aureus infections.

PROJECT SUMMARY
Chronic hyperglycemia has been linked to systemic inflammation, which may underlie several comorbidities, and
infection is a significant concern for persons with diabetes. Based on our published and preliminary data, the scientific
premise of this proposal is rooted in the finding that hyperglycemia-enhanced low-grade inflammation prompts phagocytes
to hyper-respond to pathogens, amplifying the severity of unchecked inflammatory responses, the risk of multiple organ
dysfunction syndrome (MODS) and mortality from sepsis in persons with diabetes. Also, the lack of understanding of the
pathogenesis of systemic infection during diabetes poses a major barrier to developing effective treatments. We and others
have shown that the lipid mediator leukotriene B4 (LTB4) is a critical component of the inflammatory response. However,
we have also shown that excessive amounts of this bioactive lipid enhance systemic inflammation and promote
susceptibility to infection in diabetic animals. However, 1) we did not determine the mechanisms involved in aberrant
LTB4 receptor 1 (BLT1; the high-affinity receptor for LTB4) activation in diabetic animals; 2) we did not assess whether
preventing BLT1 actions after sepsis had protective effects during sepsis and diabetes. Here, we aim to determine how
epigenetic alterations caused by high glucose exposure accelerate the transcription of genes involved in LTB4/BLT1
actions that render diabetic mice more vulnerable to systemic infections. This proposal is based on the surprising
preliminary data showing that peritoneal macrophages from diabetic mice exhibit high basal histone acetyltransferase
(HAT) activity and increased acetylation of H3 histone, favoring gene transcription. HAT inhibition decreases exaggerated
Ltb4r1 mRNA expression in diabetic animals. We also discovered that treating diabetic mice with a BLT1 antagonist 6 h
after i.v. infection increased survival and decreased bacterial load in diabetic mice. Notably, the relevance of our findings
is underscored by our preliminary observation that LTB4 levels and BLT1 expression are higher in people with diabetes
and sepsis than in individuals with sepsis and nondiabetes. These data led to our hypothesis that hyperglycemia primes
HAT activation to promote sustained and amplified BLT1 activation, leading to an intense but ineffectual inflammatory
response to systemic infection, resulting in severe MODS and enhanced death rates. We propose two Specific Aims,
which will use innovative approaches to test our hypothesis, including cutting-edge murine systems, testing newly
generated concepts (metabolic memory) in the pathogenesis of sepsis, and new potential treatment protocols that might
help translate our findings to the bedside. Aim 1 will determine whether hyperglycemia promotes metabolic memory to
sustain aberrant BLT1 activation. Aim 2 will test the hypothesis that the threshold of BLT1 activation dictates the severity
of the infection and MODS in humans and mice with diabetes. Understanding how altered metabolism intersects with
epigenetic modifications in inflammation and sepsis could lead to the development of therapeutics to reduce chronic low-
grade inflammation in diabetes that will improve the outcome of systemic infections associated with this disease.

Public health relevance
PROJECT NARRATIVE People with diabetes are susceptible to inflammatory morbidities associated with developing sepsis. However, the cellular targets involved in enhanced susceptibility to infection in this group of patients remain to be defined. This project will provide new fundamental knowledge regarding regulating inflammatory components, allowing us to take this work further in both basic and translational directions.